Developing a Novel Machine Learning Method with Partially Synthetic Data for Rapid and Precise pH Mapping in Ischemic Stroke

PROJECT SUMMARY
Neuroimaging, particularly for assessing salvageable tissue, is vital to modern stroke diagnosis and treatment
decisions. It has been previously proved that pH/diffusion mismatch provides more accurate delineation of
penumbra than the conventional perfusion/diffusion mismatch. This project aims to advance an MRI pH
imaging technique, amide proton transfer (APT), for detecting penumbra. Despite APT's sensitivity to pH,
quantifying its effect in tissues is challenging due to several confounding factors. Current techniques either fail
to eliminate these contaminations or require lengthy scan times. As a result, although APT has showed
potential in diagnosing stroke patients for a decade, it has not yet been adopted in clinical practice. Recently,
machine learning (ML) has shown promise in improving the quantification of APT effects by identifying complex
features that traditional methods often miss. However, ML often face issues such as insufficient training data
and poor-quality ground truth when trained using in vivo data. This problem is exacerbated in acute stroke
where obtaining large and high-quality training datasets is difficult. While fully synthetic data can address these
issues, practical application remains challenging due to unidentified exchangeable pools and their parameter
ranges. Our project proposes developing a new platform that generates partially synthetic chemical exchange
saturation transfer (CEST) data for training ML models, addressing these challenges. Unlike a simple blend of
measured and simulated CEST signals, the partially synthetic data integrates underlying components
including CEST, direct water saturation, and magnetization transfer effects derived from either
measurements or simulations to reconstruct CEST Z-spectrum. This approach balances simulation flexibility
and fidelity. Recently, we published this novel concept of partially synthetic CEST data for ML training under
the ideal condition of steady-state continuous-wave saturation achievable in preclinical MRI. Most recently, we
published its application in an animal stroke model which outperformed traditional APT quantification methods
and other ML methods trained on either in vivo or fully synthetic data in accurately and robustly detecting
stroke. Additional experiments on healthy humans using steady-state pulsed saturation at 3T MRI demonstrate
the method's transferability to human imaging. This proposal aims to further develop the method by extending
it to the more complex non-steady-state pulsed saturation commonly used in clinical MRI, implementing it with
interleaved acquisition and optimizing frequency offsets to shorten scan times, thus facilitating its translation to
stroke patients. We will also validate its specificity and sensitivity through simulations and control phantoms in
Aim 1, assess its ability to detect penumbra in an animal stroke model in Aim 2, and implement it at 3T MRI for
a pilot study in human patients. Upon completion, this project will pave the way for the widespread adoption of
APT imaging in identifying penumbra outside traditional treatment windows, significantly impacting healthcare.

Public health relevance
PROJECT NARRATIVE While amide proton transfer (APT) MRI imaging shows sensitivity to pH and potential in outlining ischemic penumbra, it is yet to gain widespread acceptance due to obstacles related to its accuracy in quantification and lengthy scan time. The machine learning-based methods we propose are intended to tackle these challenges, thereby enhancing healthcare outcomes.